Enrichment Program

PROJECT SUMMARY: ENRICHMENT PROGRAM
The overall objective of the Enrichment Program is to enhance the C-SiG environment by promoting
education and fostering research synergy through communication amongst its members. To do this, we
pursue five complementary SPECIFIC AIMS to: i) Support an infrastructure of electronic communication
including internal and external C-SiG Web sites and a weekly email newsletter of C-SiG announcements and
relevant seminars; ii) Conduct a monthly Center-wide seminar series, weekly seminars focused on our
mechanistic themes (i.e. intracellular signaling, cell-to-cell communication, genetics and epigenetics), and
regular journal clubs; iii) Organize an annual scientific minisymposium and an annual workshop topical
to the center mechanistic themes; iv) Facilitate extramural collaboration and technology transfer by leveraging
expertise at other institutions, including other NIDDK-funded DDRCCs via a Minisabbatical Program; and
v) Nurture junior investigators by supporting an annual research career development retreat and the
development of an Early Career Development and Research Training Program. In addition, the
Enrichment Program will continue to plan and organize one annual conference every six years for the Midwest
DDRCC Alliance (Mayo, Case Western University, University of Chicago, University of Michigan, University of
Cincinnati, and Washington University).